Role of HIV-1 integrase in virion morphogenesis and its targeting by allosteric integrase inhibitors

Abstract
New therapeutic options are needed to treat people infected with multi-drug resistant HIV-1 phenotypes. Here
we propose to both investigate and exploit the non-catalytic, essential function of HIV-1 integrase (IN) during
virion morphogenesis as a novel therapeutic target. Our highly collaborative research team has already made
important contributions toward these goals. Specifically, our studies have revealed that IN binds the viral RNA
genome (vRNA) in virions and that these interactions enable formation of properly matured, infectious HIV-1
particles. Moreover, we found that IN tetramers bind with high affinity to select vRNA elements. These findings
have begun to uncover mechanistic details behind the non-catalytic function of IN. We have been also
investigating the mode of action of a promising class of novel antiretroviral agents termed allosteric HIV-1
inhibitors or ALLINIs. Our studies have demonstrated that ALLINIs inhibit IN-vRNA interactions in virions by
inducing aberrant IN multimerization. Consequently, ALLINI treatments yield inactive virus particles with
ribonucleoprotein complexes mislocalized outside of the protective capsid. Our more recent studies have
focused on characterizing the antiviral mechanism of action of a lead clinical candidate ALLINI pirmitegravir (PIR,
STP0404) discovered by ST Pharm, Republic of Korea. This highly safe and potent HIV-1 inhibitor has recently
advanced into Phase 2 clinical trials in the USA. Here we propose to build on our highly successful research and
have set out the following two multidisciplinary and complementary specific aims. In aim1, we will continue our
investigation into the non-catalytic role of IN during virion morphogenesis. For this, we will use biochemical
assays to delineate sequence and structural features of vRNA preferentially recognized by HIV-1 IN.
Furthermore, we will determine cryo-EM structures of IN tetramers bound to cognate vRNA segments. In
addition, we’ll develop a novel and powerful in vitro model system for assembly of mature virus like particles by
using IN mediated encapsulation of vRNA inside capsid like particles. Taken together, these studies will markedly
advance our understanding of the non-catalytic function of IN during virion morphogenesis and the underlying
mechanisms for assembly of mature virions. In Aim 2, we will continue our investigation into a highly promising
investigational drug PIR. Specifically, we will delineate the mechanism for how PIR impairs IN-vRNA interactions.
Furthermore, our structural, biochemistry and virology experiments will uncover the underlying mechanisms for
drug-resistance to PIR. In turn, the findings from these studies will inform our medicinal chemistry efforts to
rationally develop improved chemotypes with an enhanced barrier to resistance. Collectively, the two specific
aims will elucidate key aspects of the HIV-1 IN biology and will exploit these insights to advance novel therapies
to treat people living with HIV-1.
1

Public health relevance
Narrative Antiretroviral therapies save lives of millions of people living with HIV (PLWH). However, evolution of multi- drug-resistant viral phenotypes is a major clinical problem, and there are limited or no treatment options for heavily treatment-experienced PLWH. We will investigate the non-catalytic function of HIV-1 integrase during virion morphogenesis and target this essential, yet clinically unexploited step in viral replication by a novel class of investigational antiretroviral agents termed allosteric integrase inhibitors, which potently inhibit wild type and all drug-resistant HIV-1 phenotypes that have emerged so far.